A new paradigm of glomerular immune cell homing

SUMMARY
This study aims to investigate a radically new paradigm of glomerular immune cell homing and to uncover the
underlying cell and molecular mechanisms and their role in physiological and renal inflammatory disease
conditions including diabetic kidney disease (DKD) and lupus nephritis (LN). As an additional translational aim,
these studies will inform the repurposing of current treatments for kidney disease and the development of new
anti-inflammatory therapies. Circulating and kidney resident immune cells are known to preferentially home in
and around the glomerulus compared to other vascular beds in both normal and inflammatory states, suggesting
the presence of unique immunomodulatory mechanisms in the glomerular microcirculation that protect the kidney
filter. However, the underlying cell and molecular mechanisms have been largely unknown. The focus of the
proposed studies is a new function of the cells of the macula densa (MD) which are strategically positioned at
the glomerular vascular entrance and traditionally known to regulate renal and glomerular hemodynamics. Our
laboratory recently identified that MD cells have the highest rate of protein synthesis among all kidney cell types
and they secrete a variety of paracrine-acting angiogenic, cell growth and patterning, and extracellular matrix
signaling proteins. Preliminary work identified the high MD-enrichment of several pathways and genes in the
inflammatory response and cellular infiltration by leukocytes (e.g., Cxcl12, Cxcl14, Ptgs2, Ptges, Anxa1, Ccn1,
Mif) and observed the MD-centric glomerular density and migration of CD44+ and CD8+ T cells in inflammatory
diseases including lupus nephritis. Our central hypothesis is that MD cells drive the preferential glomerular
homing of immune cells by the release of paracrine-acting pro-inflammatory factors including chemokines and
cytokines. This project will use comprehensive experimental approaches including new transgenic mice with
conditional, inducible and optogenetic tools (MD-mTORgof/lof, MD-Ai27, MD-Ai39, CCN1-knockout (KO), CCN1-
GFP mice), models of renal and systemic inflammation (NTS, STZ-DKD, NZM.2328 LN models), in vivo MPM
imaging, MD transcriptome analysis, in vitro cell culture and proteomics, and pre-clinical therapeutic translation.
The specific aims are to (1) Examine the global immunomodulatory role and mechanisms of MD cells under
physiological and renal inflammatory disease conditions, (2) Elucidate the renal anti-inflammatory role of CCN1,
and (3) Test the anti-inflammatory effects of SGLT2 inhibitors (SGLT2i). These newly identified MD mechanisms
may be targeted and will inform the development of future anti-inflammatory therapeutic strategies.

Public health relevance
Relevance Inflammatory kidney diseases such as glomerulonephritis, diabetic kidney disease and lupus nephritis are associated with significant comorbidities and mortalities and affect close to a third of the US population, yet their pathophysiology remains incompletely understood. Macula densa cells play pivotal roles in the maintenance of the normal structure and function of the healthy glomerulus and also in the development of glomerular injury in kidney diseases, yet their primary immunomodulatory role has been largely overlooked. We propose to study the role of macula densa cells and their pro and anti- inflammatory function in the normal and diseased kidney, and to develop new therapeutic approaches for inflammatory kidney diseases.